ABT-199 based therapies to treat neuroblastoma

Project Summary: High-risk neuroblastoma (NB) is responsible for ~13% of pediatric cancer-related deaths.
Venetoclax (VEN) is a BCL-2 inhibitor that has revolutionized adult hematological cancer care. Unique among
solid tumors, ven has demonstrated promising pre-clinical activity in MYCN-amplified NB, but likely will require
rational combinations for clinical activity. In our previous funded work, we have demonstrated VEN makes an
effective drug partner across several combination therapies (e.g. Lochmann et al. Science Translational
Medicine 2018; Dalton et al. Molecular Cancer Therapeutics 2021). In this renewal application, we focus on
two clinically translational combination therapies involving two new classes of drugs, SHP2 inhibitors which
target the MEK pathway, and BCL-xL targeting antibody-drug conjugate (ADC). In NB, one of the more
intriguing discoveries recently has been the hyperactivation of the MAPK/MEK pathway, particularly in relapsed
tumors. However, MEK inhibitors have not proven effective in preclinical studies of RAS/RAF wild-type NB,
which makes up more than 95% of cases. Here, we demonstrate that in a high-throughput screen (HTS) of a
SHP2 allosteric inhibitor, SHP099, that NB are the most sensitive group among all cancers, while MEK
inhibitors are relatively ineffective. We provide preclinical evidence that these inhibitors are favorable to MEK
inhibitors through a series of experiments. Importantly, SHP2 inhibitors form a rational combination partner with
VEN through modulation of BCL-2 family proteins. Lastly, through efforts like a HTS of the co-BCL-2/BCL-xL
inhibitor, navitoclax (Ham et al. Cancer Discovery 2016), we have demonstrated MYCN-amplified NB are
among the two most sensitive solid tumor cancers, mirroring sensitivity to the VEN data, but with marked
enhancement of sensitivity through dual targeting of BCL-xL. This concept has been previously clinically
unattainable due to on-target thrombocytopenia from BCL-xL inhibition in platelets. To circumvent this problem,
AbbVie has developed a BCL-xL targeting ADC ABBV-155. We find the antigen, B7-H3 (CD276), is widely
expressed in NB, and, as a result, combining ABBV-155 with VEN is effective in MYCN-amplified NB.
Specific Aims:
Specific Aim 1: Evaluate the efficacy and mechanism of activity of SHP2 inhibition + venetoclax in MYCN-
amplified neuroblastoma models
Specific Aim 2: Evaluate the efficacy and mechanism of activity of platelet-sparing BCL-xL inhibitors +
venetoclax in MYCN-amplified neuroblastoma models
Study Design: We will further characterize the high sensitivity of SHP2 inhibition with VEN and ABBV-155 with
VEN in vitro and in genomically-annotated patient-derived xenograft (PDX) orthotopic models of MYCN-
amplified NB. We will perform BH3 profiling (BP) to further evaluate the role of BCL-2 proteins in sensitivity and
investigate whether BP and dynamic BP will help us identify sensitive and resistant NBs to each combination.

Public health relevance
Project Narrative We have previously demonstrated through high-throughput drug screening that amongst solid tumors, MYCN- amplified neuroblastoma are the most sensitive to targeting of the anti-apoptotic proteins, BCL-2 and BCL-xL, and that targeting BCL-2 with the FDA-approved BCL-2 inhibitor, venetoclax, may be an important strategy in rational drug combination therapies. In this grant renewal, we reveal two clinically-relevant rational drug partners with venetoclax, SHP2 allosteric inhibitors, which have entered clinical trials at a blistering pace, and ABBV-155, a first in-class, in-human antibody drug conjugate BCL-xL inhibitor; in both cases, SHP2 inhibitor + venetoclax, and ABBV-155 + venetoclax, complimentarily modulate BCL-2 family proteins and induce toxicity and marked tumor responses in MYCN-amplified neuroblastoma. Overall, this grant aims to methodically test these two novel combination therapies to gather the preclinical evidence of an effective treatment regimen to put forward in a pediatric cancer with a high unmet need.